2024 Alcohol and the Nervous System Gordon Research Conference and Gordon Research Seminar

Project Summary/Abstract
This R13 application requests support for the Gordon Research Conference (GRC) and the associated GRS
on Alcohol and the Nervous System that will take place in February 2024 and 2026 meetings at the Hotel
Galvez in Galveston, TX. It seeks to build on the previous successes of the Alcohol and the Nervous System
GRCs as this meeting has become critical for budding basic and translational alcohol researchers. It also
provides a forum for interactions between trainees, early career and senior and established scientists and one
that is highly valuable for exchange of new idea and concepts. The main goal of this meeting is to promote
meaningful discussion of research developments, build new scientific collaborations, and move forward the
next generation of scientific advances in alcohol neuroscience research. Another goal is to integrate preclinical
and clinical alcohol research across multiple domains to further enrich the advancement of knowledge
regarding translational and clinical neuroscience of alcohol. To accomplish these goals, we propose: 1) To
provide a forum to promote open discussion of cutting-edge research at the forefront of alcohol effects on the
nervous system and related neuroscience areas; 2) To introduce breakthrough neuroscience approaches that
facilitate the understanding of brain mechanisms driving alcohol drinking and alcohol misuse as well as
mechanisms involved in the pathophysiology of alcohol exposure during development; 3) To promote
interaction between young and senior investigators and exchange of ideas that shape the future directions of
the alcohol neuroscience community; 4) To foster development of the next generation of diverse group of
alcohol researchers by encouraging the participation of students and postdoctoral fellows both in the alcohol
and its related research fields. This conference will focus on presentation of cutting-edge unpublished science
that is at the forefront of the field. The unique structure of the meeting integrates and encourages discussion
within the sessions and provides ample opportunities for exchange of ideas at the poster sessions and during
shared meal times. This R13 is important as it will allow support of the registration fees and/or travel support
for participants, including, junior investigators, postdoctoral fellows and/or graduate students for the GRC and
the associated GRS. Historically, this approach allowed for a high level of participation from trainees making
this conference an outstanding networking opportunity that is of great value to career development. The
inclusion of a diverse group of trainees and the establishment of an environment that welcomes free exchange
of ideas adds tremendous value to the environment of this dynamic conference. This GRC fills a critical need
for a continuing meeting that uniquely shares alcohol neuroscience research at the forefront of the field by
renowned alcohol researchers and those that are starting their alcohol research careers. We envision the GRC
and associated GRS to significantly advance our understanding of the neuroscience of alcohol addiction within
a framework intended to have implications and considerations for the treatment of alcohol use disorder.

Public health relevance
Project Narrative The 2024 Alcohol and the Nervous System Gordon Research Conference and the associated Gordon Research Seminar will provide a unique forum that brings together a diverse range of young and established alcohol researchers to discuss groundbreaking advances in alcohol neuroscience research. The innovative GRC format will promote discussions and focus on building bridges in neuroscience research between preclinical and clinical researchers, and foster a community of the next generation of alcohol researchers. The goal of this conference is to stimulate cutting edge research in the field and contribute to the advancement of alcohol research across multiple domains.